Maternal Immunization and Determinants of Infant Immunity, A FAIR, portable, cloud-based immunology data management and discovery platform

PROJECT SUMMARY
The parent project of this administrative supplement application is the NIAID U19-funded Maternal
Immunization and Determinants of Infant Immunity (MADI) program. MADI is a multidisciplinary investigation of
immunity during pregnancy and the factors linking maternal immune status to child health. MADI has brought
together diverse investigators with powerful human subjects cohorts contributing rich clinical,
sociodemographic, and high-throughput data sets. The MADI Data Management and Biostatistics Core has
designed, built and implemented a custom data management platform to support MADI’s immunological
research. This robust and flexible platform was developed in accordance with FAIR data management
principles that supports MADI with FAIR data management practices. Our goals for this administrative
supplement funding are to further develop this tool to include automated data sharing functions; to develop
MADI data sets as a data asset compatible with the NIAID Data Ecosystem; and to develop the platform as an
open-source containerized software that can be freely shared with investigators in the wider community in
support of their data management and sharing needs.

Public health relevance
PROJECT NARRATIVE The Maternal Immunization and Determinants of Infant Immunity (MADI) program aims to understand the maternal factors governing immune response during pregnancy and in early life. The MADI Data Management and Biostatistics Core has previously developed a data management tool for the program that provides access by program investigators to all program data. With this supplement funding, the Core aims to enhance its data management system with updated data sharing processes that will improve ease and accuracy; to develop existing data sets for compliance with common standards; and to deploy via the cloud free software that other research teams can use to support their own research in immunology and infectious disease.